Assessing the Impact of Patient Factors on Therapeutic Capabilities of BMAC for Osteoarthritic Pain

Post-traumatic osteoarthritis (PTOA) is a debilitating condition of articular joints that is associated with pain, loss
of activity, and reduced quality of life. Non-battle musculoskeletal injuries in active Military members are higher
than civilian counterparts. Due in part to this increased risk of traumatic injury, and the occupational demands of
high-impact repetitive joint use, osteoarthritis incidence is almost three times higher in the military vs civilian
population by the age of 40. Current options (platelet-rich plasma, hyaluronic acid) for joint preservation are
being gradually replaced by autologous cell-based injections, including bone marrow aspirate concentrate
(BMAC), that aim to reduce intra-articular inflammation and relieve pain. Limitations for autologous sources of
BMAC expose these therapies to donor variation in product and efficacy. Age and PTOA can alter the cellular
composition and function of bone marrow, though how these changes may affect efficacy of BMAC injections for
PTOA pain relief remains unknown.
In this proposed project, we seek to devise a strategy to facilitate pain relief and joint preservation with BMAC
injections in a preclinical model of PTOA. Our central hypothesis posits that donor age, sex, and PTOA status
impact BMAC efficacy in relieving osteoarthritic pain and that personalized regimens of endurance exercise
could prime bone marrow to become a potent immunomodulatory product. We will address this objective with
two specific aims: 1) Determine the effect of patient factors (age, sex, PTOA) and exercise on BMAC composition
and immune-modulatory potential; 2) Evaluate the potential of individualized pre-habilitation to increase the pain-
relieving and joint-preserving capabilities of BMAC.
In the first aim, we will harvest and evaluate BMAC from 3 mo and 12 mo male and female Lewis rat populations
with and without induced PTOA. We will exercise a subset of rats daily. We will characterize the cellular
composition and immune-modulatory capabilities of the BMAC from all donors. We will then directly compare
BMAC quality from young vs. middle-aged, and osteoarthritic rats and evaluate whether exercise can rejuvenate
BMAC immune-modulatory potential. In the second aim, we will test the efficacy of these BMAC products in vivo
using a preclinical model of PTOA. We will assess longitudinal pain and function, as well as end-stage
inflammation and tissue health. We will then link the compositional and functional changes of BMAC due to age,
sex, PTOA, and exercise to in vivo pain relief. Findings from the successful completion of these aims will be well
positioned for expedited clinical translation to establish guidelines for quality control of BMAC and to encourage
clinicians to implement pre-habilitative interventions.

Public health relevance
Project Narrative Post-traumatic osteoarthritis (PTOA) is a debilitating condition of articular joints that is associated with pain, activity loss, and reduced quality of life. Incidence of PTOA and similar degenerative conditions is almost three times higher in the military vs civilian population by the age of 40. Intra-articular injections of cellular products, including bone marrow aspirate concentrate (BMAC), are becoming standard of care for joint preservation and pain relief. Most of our data on the best use for BMAC rely on studies using allogenic cells from young, healthy donors to treat PTOA in young, otherwise healthy rodents rather than autologous sources The objective of this proposal is to evaluate how patient factors (age, sex, PTOA) and physical interventions impact BMAC efficacy in relieving osteoarthritic pain. Successful completion of this project will provide translatable evidence whether pre-habilitation of all or a subset of Veterans prior to BMAC harvest and injection can improve relief of joint pain.